Mechanisms and effects of pallidal deep brain stimulation on levodopa resistant motor signs in Parkinson's disease

Project Summary/Abstract
A large percentage of people with Parkinson’s disease (PD) will develop debilitating levodopa-resistant
impairment in postural stability and gait disturbances, including freezing of gait, over the course of disease. Many
of these individuals will be become candidates for treatment with deep brain stimulation (DBS) due to disease
progression and adverse effects associated with prolonged use of dopamine replacement therapy. While
subthalamic nucleus (STN) and globus pallidus (GP) DBS using standard clinical targets and stimulation
parameters can be highly effective for the treatment of the cardinal motor symptoms of PD, both treatments often
fail to control levodopa-resistant motor features of PD. Previous studies, and our ongoing research, have
provided evidence that the most effective site for alleviating akinesia and bradykinesia was the
posterolaterodorsal region of the GPi, near the border between the internal and external (GPe) segments, dorsal
to the region typically targeted for GPi DBS. Moreover, DBS in this region can be effective for levodopa-resistant
motor signs. Currently, the mechanisms mediating the prokinetic effects of stimulation near the GPi-GPe border
(GPi/e-DBS) are poorly understood. The primary goal of this project is to gain a better understanding of the
pathways mediating the benefits of GPi/e-DBS on levodopa-resistant motor signs. The project will leverage
technical advances in DBS lead design that allow current steering and adjustment of electric field orientation, in
conjunction with patient-specific computational models, to tune stimulation to preferentially activate prokinetic
axonal pathways (Aims 1 and 3). In addition, we will wirelessly record local field potentials from leads chronically
implanted in people with GP DBS (Aim 2), and use wearable technology to monitor gait and mobility during
chronic stimulation in the home environment (Aim 2). Aim 1 will examine the effects of altering the orientation of
the electric field induced by GPi/e-DBS to be either parallel or orthogonal (lowest or highest net axonal activation
thresholds, repectively) to putative striato-GPi and GPe to GPi afferent pathways (prokinetic connections of the
basal ganglia). Aim 2 will use the Medtronic Percept™ PC DBS system with active sensing to study: (i) pallidal
oscillations associated with the re-emergence (wash-out) and suppression (wash-in) of gait impairment with
GPi/e-DBS, (2) the up- and down-stream effects of GP DBS on motor network activity using 3T fMRI, and (iii)
the relationship between fluctuations in gait and GP LFPs during activities of daily living (recorded over 4 weeks).
Aim 3 will examine the effects of stimulation in the associative/limbic region of the GPe on gait and postural
control with and without an increased cognitive load (dual-task). Together, these experiments will provide critical
insight into the mechanisms and effects of GPi/e-DBS on basal ganglia and cortical-subcortical circuitry and
measures of gait and postural control. This could lead to a new approach to using GP DBS to treat levodopa-
resistant motor signs of PD.